Light-Seq: Spatially targeted profiling of transcriptomic states in cells and tissue

Summary
We will develop a new spatial-omics platform, Light-Seq, for spatial indexing of intact biological samples using
light-directed DNA barcoding in fixed cells and tissues followed by ex situ sequencing. Our light-directed
barcoding strategy will enable user-directed, in situ selection of rare, disjoint cell populations for full-
transcriptome sequencing based on morphology, location, or protein expression without dissociation. We will
develop Light-Seq as a spatial-omic DNA barcoding platform capable of extracting the transcriptomic information
from single-cells, scalable to uniquely address thousands of user-defined regions, and can be applied in both
fixed and FFPE clinical samples for direct applications in human health. We envision that the Light-Seq platform
will be a scalable, cost-effective, and flexible approach to spatial transcriptomics that allows the user to define
spatial regions in tissue for NGS sequencing. Light-seq can thus serve as a low barrier-to-entry platform for
spatial transcriptomics for many pathologists and researchers, and would be a key driver for a wider adoption of
spatial transcriptomic tools.

Public health relevance
Narrative To comprehensively understand the cellular states that drive biological function and pathology, it would be ideal to identify biomolecules in their spatial context within fixed cells and tissue by combining both imaging-based screening with omics-level profiling by next generation sequencing (NGS). We propose to develop a light- directed spatial barcoding platform for highly parallelized, deep profiling of individual cells transcriptomic states within user-defined areas of tissue and clinical samples.